Data-Science Guided Study and Design of Phosphoranyl Radical-Mediated Reactions

The discovery of new pharmaceutical compounds relies on the ability to synthesize increasingly complex
scaffolds with desirable biological and pharmacokinetic properties. To foster continued growth in this area, new
transformations to access small organic molecules are required. Methods which form new C–N bonds are highly
valuable, as over 50% of the top two hundred drug compounds contain at least one N-atom. Recently, the Doyle
group has demonstrated that sulfonamides can be activated for hydroamination reactions using
photoredox/phosphine catalysis through α-scission of an intermediate phosphoranyl radical. While phosphoranyl
radicals have been used to enable a variety of transformations through β-scission, transformations proceeding
through α-scission are underdeveloped despite providing an approach to form C–N or C–heteroatom bonds. To
promote the development of new transformations relying on phosphoranyl radicals, a better understanding of
the factors controlling α- versus β-scission is required. We propose leveraging data science to build a
comprehensive, predictive model explaining phosphoranyl radical α- versus β-scission selectivity. This model
will employ data collected from a model reaction to train predictive machine learning algorithms, overcoming
limitations in our current mechanistic understanding of this process. In addition, we will leverage phosphine
activation of N-nucleophiles for a novel alkene carboamination reaction based on a photoredox, phosphine, and
nickel tandem catalysis. This unique approach relies on the ability of phosphine catalysis to form N-centered
radicals and the established reactivity of nickel catalysis towards C-centered radicals to enable a desirable
carboamination reaction without the requirement of pre-functionalized amines or stoichiometric reagents. In
addition, this approach is amenable to carboamination with N-heterocycles. Overall, the proposed research is
comprised of two aims: (1) develop predictive machine learning algorithms to determine factors influencing the
selectivity of α- and β-scission of phosphoranyl radicals, and (2) develop a photoredox, phosphine, and nickel
catalysis mediated carboamination reaction. These aims will be explored concomitantly with data collected in
aim 1 being applicable to, but not necessary for, the completion of aim 2. Aim 1 will contribute significantly to our
understanding of phosphoranyl radical reactivity, promoting the design and development of new transformations
relying on this powerful mechanistic step. The transformation developed in aim 2 will address challenges in
currently available carboamination reactions to generate desirable C–N and C–C bonds and will provide a
framework for future reactions combining photoredox, phosphine and nickel catalysis. Overall, this work
represents a significant advance in the field of phosphoranyl radical reactivity and is expected to have
longstanding impacts on future applications of these approaches to pharmaceutically relevant transformations.

Public health relevance
Transformations that form C–N bonds are essential to the synthesis and exploration of pharmaceutical compounds, with C–N coupling reactions contributing to 23% of the reactions performed in medicinal chemistry campaigns. Phosphoranyl radical-mediated reactions have the potential to significantly increase the diversity of C–N bond forming transformations, which in turn would facilitate the synthesis and discovery of new biologically active compounds. The work proposed herein would offer a significant contribution to the field through delivering a machine learning model which will be used to gain new mechanistic understanding of phosphoranyl radical scission selectivity and will aid in extending phosphine catalysis to more complex transformations, both of which will have longstanding impacts in the development of novel C–N bond forming reactions.